University of Washington LURN II Research Site

Project summary
This proposal responds to RFA-DK-18-510, which requests applications for Research Sites to continue in the
Symptoms of Lower Urinary Tract Dysfunction Research Network (LURN). In this application, the University of
Washington (UW) seeks support for a Research Site to participate in efforts to unravel the clinically
confounding symptoms of the lower urinary tract. This proposal was developed following the guidelines
stipulated by the National Institute of Diabetes, Digestive and Kidney diseases (NIDDK). The aim of the
proposed UW Research Site, in conjunction with the Data Coordination Center and LURN Research Sites, is to
develop and validate symptom-based instruments to measure lower urinary tract symptoms both in men and
women, and to better define the subtypes of persons with lower urinary tract symptoms. The key
responsibilities of the Research Site will be to adopt the study protocols developed by the LURN investigators,
validate the developed Patient Reported Outcome (PRO) measures, recruit study participants, and conduct
extensive characterization (subtyping) of them.

Public health relevance
Project Narrative The aim of the proposed UW Research Site, in conjunction with the Data Coordination Center and existing LURN Research Sites, is to develop and validate urinary symptom-based instruments both in men and women, and to better define the subtypes of men and women with lower urinary tract symptoms. The relevance of the project is to identify subgroups of persons with urinary symptoms, in order to find the causes of the symptoms and identify better treatments.